UKY DENTAL COBRE: ADMINISTRATIVE AND EDUCATIONAL CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Administrative/Educational Core of the CBBO/SD has facilitated the research and training goals of the COBRE by: (1) To schedule and organize meetings for the CBBO/SD participants;(2) To organize meetings of the Scientific Advisory Committee (SAC);(3) To provide fiscal administration and accounting;(4) To interface with institutional administration in new faculty recruitment;(5) To oversee the funding of new pilot projects;(6) To interface and provide appropriate reporting to the NIH and other regulatory agencies;(7) To sponsor and organize research career development and training opportunities;and, (8) To provide outcomes assessment of the CBBO/SD.